ATTENTION DISORDERS AS ASSESSED BY EVENT-RELATED BRAIN POTENTIALS

The aim of this project is to investigate the roles of event-related brain potentials, attention, and information processing and their interrelationships in the etiology, pathology, and prognosis of psychiatric and neurological disorders. Major emphasis is on the diagnostic specificity of disorders of attention and cognition and identification of the specific aspects or stages of information processing underlying observed decrements in performance. Concurrently recorded event-related brain potentials and performance on cognitive tasks are used to define mechanisms of cognitive failure in subjects with diagnoses of schizophrenia, seasonal affective disorder, seizures, attention deficit disorder, learning disorders, eating disorders, and dementing diseases. Event-related brain potentials are also used to investigate the role of altered neurochemical mechanisms by comparing drug-induced electrophysiological and behavioral effects with those seen in the various disorders. Psychological correlates are investigated by relating the data to extensive neuropsychological, psychiatric, and personality measures as well as performance on behavioral tasks.